Administrative Core

PROJECT SUMMARY/ABSTRACT (Administrative Core)
The broad goal of the TU Center for Biomedical Research/Research Centers in Minority
Institutions (CBR/RCMI) Program is to provide continued support for further development and
expansion of its institutional biomedical infrastructure to conduct` an diversify the health
disparities research. The long-term objective is to provide administration, resources, and support
aimed at increasing the number of research investigators who acquire extramural funding. This
will be accomplished by a creating a stimulating environment that promotes a culture of efficient
and timely administrative support that will increase the number of funding submissions and/or
acquisitions of extramural funding in biomedical and behavioral research. The Administrative Core
(AC) will provide multi-functional administrative support through pre- and post-award services,
implementation of objectives, directions and guidance, and oversight to ensure that the specific
aims and goals are accomplished. The goals of the TU CBR/RCMI Program application for 2023-
2028 are to continue development and support for a competitive, multidisciplinary, collaborative
environment that advances an understanding of diseases that disproportionately affect African
Americans and underrepresented minorities. The AC that will foster this environment consists of
the Multiple Principal investigators (MPI’s), Program Manager (PM), Planning and Evaluation
Manager (PE), and the CBR/RCMI Advisory Committee (RAC). Members of the AC will assist
with the development of concepts, directions, monitoring, and review of research activities and
will oversee implementation of program initiatives. The AC support staff includes the Research
Center Office - Assistant Director, Academic Support Services, Biostatistician,
Information/Publication Services, and RCMI Office Manager. Staff members, who are responsible
for day-to-day program management, serve as a liaison between the CBR/RCMI program MPI’s,
researchers and administrative oversight departments (i.e., Office of Sponsored Programs,
Contracts and Grants, federal funding agencies, purchasing, travel and other administrative and
academic departments). AC staff will attend meetings and workshops for professional
development and ensure compliance with agency and institutional policies. The primary role of
the AC staff is to assist with professional growth of investigators by providing services to promote
the development of funding for improved quality and quantity of federal/state investigator-initiated
grant submissions. Services provided by AC staff will assist in eliminating administrative burdens
on investigators to allow efforts advancing biomedical technologies, core development, and
training in areas of drug development and molecular biology. A concerted effort will be made to
utilize these applications to expand research experiences and expertise of minority scientists
directed to diseases disproportionately affecting minority groups in order to eliminate health
disparities.